Modulation of Human Cells by Virulent Francisella tularensis

Summary: Francisella tularensis, the causative agent for tularemia, can infect humans by a number of routes, including vector-borne transmission. However, it is inhalation of the bacterium, and the resulting pneumonic tularemia, that represents the most dangerous form of disease. This is due to the short incubation time (3-5 days), non-specific symptoms, and a high mortality rate (greater than 80%) in untreated individuals. Furthermore, F. tularensis has been weaponized by both the United States and the former Soviet Union making it a viable candidate for use as a biological weapon. Despite over 80 years of research on F. tularensis around the world, very little is understood about the dynamic interaction of this bacterium with the host, especially following aerosol infection. My laboratory has established that, similarly to murine cells, human dendritic cells are acutely susceptible to infection with F. tularensis, but fail to produce pro-inflammatory cytokines or undergo maturation. Further, virulent F. tularensis actively interferes with the ability of human DC to respond to secondary stimuli. Understanding the mechanism by which F. tularensis actively suppresses DC function is a central directive of my laboratory. We are tackling this directive in two different ways. First, we are analyzing the role Francisella lipids play in mediating anti-inflammatory responses. Structures present on the surface of bacteria are the first components encountered by the host cell. Thus, it is possible that, in the context of F. tularensis infections, these structures contribute to the early, rapid suppression of human dendritic cells. Bacterial lipids represent one such structure. Preliminary evidence in our lab suggests that lipids associated with the outer membrane of F. tularensis can potently suppress inflammatory responses in human dendritic cells. We are currently identifying the specific lipid(s) responsible for this suppression and the mechanism by which they interfere with human dendritic cell functions. Second, we are exploring the intracellular host pathways modulated by F. tularensis, which negatively regulates human dendritic cells through multiple pathways. For example, if the replication of extracellular bacteria is restricted, the ability of human dendritic cells to produce TNF-alpha in response to other microbial stimuli is restored. However, a similar restoration of IL-12 production is not observed. We have demonstrated that rapid induction of IFN-beta by F. tularensis potently suppresses production of IL-12 in human dendritic cells. We are currently dissecting the specific pathways and molecular mechanisms by which IFN-beta modulates host responses in F. tularensis infected human dendritic cells. In addition to aiding in the development of novel vaccines and therapeutics, identification of bacterial products capable of negatively regulating specific host pathways (while leaving others intact) may provide new targets for therapeutics directed against cancer and autoimmune diseases. Recent evidence suggests that there is a crossover of our two specific aims in that lipids derived from F. tularensis interact with specific signaling transduction and transcription elements required for Type IFN signaling. These elements are also involved regulation of IL-12p40 transcription. My laboratory is continuing to identify the specific signaling pathways manipulated by F. tularensis and the bacterial components required for this interference.